Longitudinal evaluation of optical and neural factors leading to juvenile myopia

Summary/Abstract:
Projections indicate that over 50% of the world’s population will have myopia by the year 2050. To develop
successful myopia prevention programs, it is critical to first discern the optical image formation and visual
processing characteristics in children who develop myopia. Considerable evidence points to the quality of the
visual image and absence of blur as the main drivers for normal ocular growth and emmetropization. Human
eyes have complex optical, retinal and visual processing structures and functions. Any and all of these factors
affect the perception of image quality, and may, therefore, be catalysts of the failure to control ocular
elongation and myopia development in children. To better understand the mechanism(s) for the development
of myopia, these factors ought to be measured in the same children over a longitudinal period, prior to and
after the onset of myopia.
The immediate objective of this prospective longitudinal study is to tease out retinal image quality and visual
processing factors that may contribute to the development of myopia. We will recruit two groups of young
children, limiting eligibility to only children who are either at high risk or low risk to develop myopia during the
duration of the study. The following factors will be assessed in each child at 6-month intervals over a period of
3 years: (1) Optical quality of the image formed at the retina. We predict that: dynamic accommodation is less
stable prior to myopia development, causing degraded retinal images; and children who develop myopia will
show degraded image quality across the retina. (2) Retinal responses to image blur will be measured using
pattern electroretinography while subjects observe images blurred with various types and amounts of
simulated optical blur. We predict that children with impaired retinal responses will develop myopia. (3)
Processing of blur will be measured using blur detection and discrimination thresholds and contrast sensitivity
functions across the visual field to the same types of image blur described in (2). We predict that visual
processing of blur will be impaired in children who develop myopia.
We will create individual models of interactions between the three measures: optical image quality, retinal
function and visual processing. We predict that deficits in retinal image quality, retinal function and visual
processing or their interactions lead to a cycle of abnormal representation of blur, which would in turn cause
the development of myopia. Understanding the signals that activate myopia development will have a significant
impact and will help us and other researchers to design future clinical studies for the prevention and control of
myopia. Knowledge of the mechanism(s) for myopia development is essential for the design of effective
individualized interventions in children at risk for myopia, which can be assessed in subsequent clinical trials.

Public health relevance
Narrative: The proposed study is relevant to public health because here is an urgent need to prevent juvenile myopia (nearsightedness) — projections indicate that over 50% of the world’s population will have myopia by the year 2050. Furthermore, the increasingly earlier onset of myopia in children with consequent higher progression rates is generating an epidemic of potentially blinding, high myopia. As a necessary step in developing successful myopia prevention programs, this longitudinal project will help understand the ocular structure and visual function characteristics of myopia development in children with an investigation of ocular, retinal and visual processing factors prior to and after the development of myopia in children .